Opioid use disorders: UF Pharmacy medications discovery and development

PROJECT SUMMARY
This project is submitted under Funding Opportunity Announcement (FOA) Number: RFA-DA-19-002.
Opioids have been significantly over-prescribed and are associated with numerous deaths, resulting in the
Nation’s current opioid crisis. The FDA recently approved the α2 adrenergic agonist lofexidine as a non-addictive,
non-opioid treatment for opioid use disorder. This preclinical drug development effort stems from the
psychoactive, natural product, Mitragyna speciosa (kratom), a Thai medicinal herb used as a self-treatment for
opioid use disorder. Mitragynine, the plant’s most abundant alkaloid, is a low efficacy µ receptor agonist with G-
protein signaling bias. Our preliminary studies suggest that mitragynine has limited abuse liability, and interacts
with non-opioid CNS targets including α2 adrenergic receptors, which have not been exploited in its unique
mechanism. A single drug (mitragynine) that interacts with both opioid and α2 adrenergic receptors would offer
a highly innovative approach for treating opioid use disorder. The work planned here, involving a collaborative,
interdisciplinary team, will examine the pharmacophoric elements of mitragynine through synthetic derivatives in
an approach that led to the understanding of the essential pharmacophore of morphine. We will use a
combination of chemical and prodrug synthesis, in vitro metabolic stability, affinity and efficacy analysis,
behavioral assays predictive of receptor mechanism (drug discrimination), abuse (self-administration), and
untoward effects (respiratory depression, tolerance, and dependence), and in vivo ADME assays. Mitragynine
analogs are expected to yield innovative compounds with a pharmacological mechanism that includes opioid
and adrenergic activity. Our efforts to identify the pharmacophoric requirements of mitragynine will lead to
templates for the design of novel opioid receptor ligands; this will greatly improve the knowledge of interactions
of these structurally novel compounds with opioid receptors and facilitate the development of these ligands as
treatments for opioid use disorders. The specific aims of the 2-year UG3 phase are as follows. AIM 1: Identify
opioid pharmacophoric requirements of mitragynine analogs through deletion design and analog stability; identify
mitragynine prodrugs. AIM 2: Investigate mitragynine analogs in drug discrimination, self-administration, and
respiration assays. Analogs exhibiting desired metabolic stability, bioavailability, blood-brain-barrier penetration,
binding characteristics, and behavioral activity will be further studied in the UH3 phase as follows. AIM 3:
Establish comprehensive in vivo ADME of mitragynine analogs and prodrugs. AIM 4: Assess mitragynine
analogs and prodrugs in tolerance, dependence, and withdrawal assays. The results of this project will provide
a more comprehensive understanding of the chemical requirements of the putative recognition elements of
mitragynine-related ligands at opioid and α2 adrenergic receptors. Ultimately, the potential use of mitragynine
and its analogs as templates for the development of a new treatment for opioid use disorders will be realized
that may have the potential to yield a safe, effective FDA-approved pharmacotherapy.

Public health relevance
PROJECT NARRATIVE Given the current opioid crisis in the United States, there is an urgent need for therapeutics with unique and novel pharmacological mechanisms for opioid use disorders. Recent investigations into mitragynine, the major alkaloid found in Mitragyna speciosa (Kratom), have identified a novel approach to new therapeutic mechanisms that have not been previously explored. This involves the combination of G-protein biased µ- opioid receptor and a2 adrenergic receptor activation. Our studies indicate that mitragynine does not exhibit abuse-related effects and can attenuate opioid intake. This application seeks to identify analogs and prodrugs of mitragynine that have drug-like properties as potential innovative treatments for opioid use disorder.